PSU INTREPID Program

DESCRIPTION (provided by applicant): This application focuses upon conveying the enthusiasm of scientific discovery to undergraduates representing those groups who are underrepresented in the health care workforce. Such students are virtually absent from short-term research exposure programs during their college careers. By providing students a hands-on research opportunity at the Penn State University (PSU) in the context of the foundational missions of the National Heart, Lung and Blood Institute (NHLBI), it is our goal to pique student curiosity about the biosciences and to instill in them the confidence to explore postgraduate pathways leading to productive careers in the health and bioscience fields. Our program, termed PSU INTREPID (Introduction of a Novel Tiered Research Experience Promoting Inclusion and Diversity), will gradually immerse minority students into the research arena in year one at the College of Medicine, where they will be provided with hands-on laboratory experiences during the eight weeks of guided instruction. The program will consist of didactic modalities including human simulators, bench-top experiments, research projects, computer data mining, and others; moreover, the students, who will work in teams of two and explore the four subject areas (heart, blood, lung and sleep), will develop a network of mentors who will support the students through the two years of the program and beyond. Once confident in their laboratory skills and introduced to the subject of responsible conduct of research, the students will perform the second tier of their research training at University Park, where they will conduct a specific research program tailored to their interests. The PSU Summer Symposium and other forms of scientific support (breakout sessions, mini-lectures, and seminars) will be available in tier two as deemed necessary. The third tier will correspond to the creation of a support network of mentors extending beyond the INTREPID laboratory years that will aid interested students in the matriculation into postgraduate programs. It will also be important to determine whether other novel elements of the programs are of merit. These include (1) the application of simulation in concert with teaching/instructive modalities in year one; (2) the provision of two distinct venues in year one (medical school) and year two (university/college town); (3) the creation of an extended mentoring network; (4) the close partnership between Penn State and two local HBCU (Historically Black College/University) partners; (5) the creation of a career pathways network beginning with local high schools, extending to the HBCUs and local universities, and passing through the INTREPID program and on to postgraduate programs at both PSU and other research-intensive universities; and finally, (6) the generation of a partnership with both the PA Department of Health, Office of Health Equity, and the Highmark Blue Cross Blue Shield Health Company of PA, representatives of which will inform the trainees of health career opportunities.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Penn State University will provide eight minority undergraduate students with two, successive eight-week summer research experiences. Students will undergo gradual exposure to discovery science in year one (at the College of Medicine) through the focus upon concept strengthening and skill development via hands-on experimentation; this will be followed in year two by independent research in dynamic laboratories at University Park. The hypothesis that will be tested is that by gradual immersion, accompanied by strong and extended mentorship, minority students will better develop an interest to pursue careers in health infrequently considered as viable future options, and thus, level the diversity imbalance extant in the current workforce. (End of Abstract) Project Narrative The Penn State University will provide eight minority undergraduate students with two, successive eight-week summer research experiences. Students will undergo gradual exposure to discovery science in year one (at the College of Medicine) through the focus upon concept strengthening and skill development via hands-on experimentation; this will be followed in year two by independent research in dynamic laboratories at University Park. The hypothesis that will be tested is that by gradual immersion, accompanied by strong and extended mentorship, minority students will better develop an interest to pursue careers in health infrequently considered as viable future options, and thus, level the diversity imbalance extant in the current workforce. __SpecificAimsTextDelimiter__ Specific Aims: The long-term objective of this proposal is to increase minority involvement in the health care professions. The current under-representation of minorities1 in the health care workforce poses a problem plaguing the United States. This could further weaken our future global standing in health care. While such individuals are not only underrepresented in the health care professions, the National Science Foundation has observed that these same people fare poorly with respect to obtaining any introduction to the research world prior to graduation from college (http://www.nsf.gov/statistics/showpub/.cfmTopID=2&SubID=27). One plausible interpretation is that these students lack a discovery research stint in the undergraduate years, an experience that provides students with the added stimulation, confidence boost, and broadening of vistas partially required for the continuation of their postgraduate education in the biomedical and the behavioral social science fields (1). Currently, the provision of hands-on, summer laboratory experiences is a common means of potentially promoting diversity within advanced degree programs (2-4). While such initiatives are intrinsically valuable and build academic skills (5), certain weaknesses may arise which pose concerns and which raise the question: do these programs work as well as they could and by necessity, should? This application challenges the current paradigm and offers a novel alternative whose level of merit will be evaluated and compared to standard "short-term" programs. We borrow from the culinary world in which it is well known that potatoes need to reach boiling beginning with their immersion in cold water; if the cubes are immediately immersed in hot water the outside cooks long before the inner potato, leading to mushy vegetables. Likewise, undergraduate students immediately immersed into a throbbing laboratory with sporadic mentorship and spotty guidance sometimes fail in their understanding of the conceptual nature of the science they are asked to perform. There is usually no longitudinal support and guidance, except that expected of a single busy mentor. Thus, we will adopt a multi-tiered experience in which eight students will first undergo a hands-on, controlled learning and training environment at the Penn State College of Medicine (PSCOM) (tier one), followed by a second summer of discovery science at University Park (tier two). Students will work as teams of two, equivalent in number to the four areas of interest of the National Heart, Lung, and Blood Institute (cardiovascular, hematology, pulmonology and sleep). The students will be paired with multiple mentors who will facilitate sustained communications following the students' graduation under the supervision of the Principal Investigator. Thus, tier three will constitute programmatic evaluation placed in context of the creation of a substantive, student support network both during and following completion of the formal program. Specific Aim 1: To promote the understanding of, and enthusiasm toward, the performance of biomedical research through administration of a controlled, hands-on approach during summer one at the Penn State College of Medicine (PSCOM). The approach will consist of a variety of hands-on activities including the use of human simulators and laboratory experiments, in concert with mini-lectures, problem-based learning sessions, seminars, skills development, field trips, and others. Over a two-month period, students will develop their laboratory, research, computer, and writing skills in concert with necessary "softer" skills (team work, communication/public speaking), and will develop an understanding of the complex, but rewarding, endeavor of biomedical research performed in an ethical and professional (i.e., responsible) manner. A mentor "network" (or nexus) will begin to emerge at this time, which is critical for the development of the minority scholar. Specific Aim 2: To expose the same group of students in the summer of year two to a strongly- mentored, independent research experience in a laboratory at Penn State's University Park campus site. The approach will be to place students into a laboratory at University Park (UP) whose focus falls into one of the NHLBI mission areas (heart, blood, lung and sleep). Students will receive individual projects and detailed instruction related to successfully carrying out the defined aims of their project; such activities will be supported from each student's learning and subsequent understanding accrued during year one. The Principal 1 We wish to make clear that by minority, we refer to women, people of diverse racial and/or ethnic backgrounds, and those persons afflicted with a disability. Investigator (PI) and Co-PIs will ensure that significant time is spent in the mentoring of the students, thus ensuring the thorough understanding of their work at both technical and conceptual levels (6). Additional UP mentors, both faculty and students (postdoctoral fellows, graduate students, etc.) will be added to each student's PSU support network and will be geared toward preparing and guiding the students in matriculation into a postgraduate professional program. Specific Aim 3: To evaluate the potential short- and long-term successes of the PSU INTREPID undergraduate research experience and to compare it to a more traditional, in-house short term (single experience) summer program. This educational research thrust will determine whether the INTREPID program provides added strength in fostering student learning, understanding, and ultimate participation in pathways leading to one of the many careers in medicine (a particular focus will be on graduate school). In essence, does this multi-tiered and gradual immersion into the research arena provide added value over the traditional "in-and-out" summer research experience, which is currently de rigueur for undergraduates interested in biology research careers?